Admin Core

Project Summary – Administrative Core
The goal of the CORT is to elucidate mechanisms of action of osteoporosis anabolic therapies,
and to understand why they stop working over time. In doing so, the CORT will accelerate
translation knowledge to improve our understanding of osteoporosis pathobiology. To achieve
this goal, the overall focus of the CORT is to define the cellular and molecular mechanisms of
action of currently-used osteoporosis anabolic agents in humans. A highly-collaborative, multi-
disciplinary, international network of investigators based at several Harvard Medical School-
based institutions and Imperial College London have come together to tackle this challenge.
The goal of the Administrative Core is to provide administrative support for all aspects of the
CORT and its scientific mission. To achieve this goal, three specific aims are proposed. First,
the Administrative Core will support the scientific goals of the CORT via coordinating
management across projects, supporting a pilot award program, supporting patient recruitment
efforts, and facilitating scientific and regulatory reporting. Second, the Administrative Core will
provide infrastructure and timely support to ‘unburden’ CORT investigators by coordinating
teleconferencing, meeting planning, travel arrangements, and performing post-award grants
management. Third, the Administrative Core will function as a ‘hub’ for engagement and
dissemination of CORT scientific activities with the broader academic skeletal biology and
osteoporosis research communities. These efforts will rely on integration with existing
dissemination networks for translational science, a Visiting Professor series, and developing a
robust series of platforms to publicize the CORT mission. The Administrative Core leadership
structure will involve a director and associate director with appropriate expertise in fundamental,
translational, and clinical skeletal biology research, with support from an appropriately-selected
External Advisory Committee panel. In sum, the Administrative Core represent an integral
component needed for the success of this collaborative, multi-disciplinary, inter-institutional
translational research program.

Public health relevance
Project Narrative – Administrative Core The Administrative Core will support the scientific missions of this Center of Research Translation. To serve this function, the Administrative Core will provide key administrative and oversight support so CORT investigators can focus on collaborative translational science. In addition, the Administrative Core will oversee awarding pilot and feasibility grants to further enhance the scientific mission of the CORT.